Nanomechanical studies of cells and biomolecules

Abstract
The research in our laboratory is centered on the development of force-based mechanical
approaches to biomolecular and cellular imaging, and leveraging these capabilities to study a
number of questions in biomolecular dynamics and cells mechanics. Our approach to imaging
offers new capabilities in probing chemical, mechanical and electrical characteristics of
biological systems from molecules to cells. In biomolecular imaging, we focus on problems in
structural biology that can benefit from direct imaging in physiologically relevant conditions
where mechanical approaches like atomic force microscopy (AFM) have advantages. We
currently develop an AFM-based method to image dynamics of RNA/protein complexes and
membrane proteins with Angstrom scale resolution. In cell mechanical studies, we recently
developed a cell stiffness imaging method that provided unprecedented spatial resolution,
which helped reveal nanoscale patterns in cell stiffness that are described by precise
mathematical relationships. Existence of these patterns are not predicted by the current
quantitative models of cell mechanics. We developed a new model that not only explained our
findings, but also made new testable predictions that we subsequently confirmed. These
molecular and cellular studies shape the current research goals in our laboratory. On the
biomolecular imaging front, our goal for the next five years is to develop our technology to
achieve imaging of biomolecular dynamics in physiologically relevant conditions with Angstrom-
scale resolution. Currently, such high-resolution data is mainly coming from methods that work
with frozen or crystallized samples, which prevent observations of biomolecular dynamics. On
the cell mechanics front, our goals for the next five years include further developing our cell
mechanical model to address a large discrepancy between results measured by different
methods used by researchers. We believe the discrepancy is not due to technical problems of
various methods, but rater due to underlying assumptions about contact mechanics of cells,
that is, a conceptual issue. Addressing this discrepancy can help better predict cell mechanical
behavior in physiological contexts. We are also interested in investigating electromechanical
coupling in cell membranes and have already built a uniquely suited experimental setup to
probe electromechanical coupling in cell membranes. We are motivated by our recent
observations of strong coupling effects and potential effects of coupling on gating of ion
channels and the morphology of membranous organelles. Overall, the vision of our research
program is set by the important roles of nanoscale mechanical interactions in biology, and we
develop biophysical models and experimental capabilities to realize our vision.

Public health relevance
PROJECT NARRATIVE We are developing new nanoscale mechanical techniques and theoretical models to study cells and biomolecules, and we use these approaches to visualize dynamics of biomolecules in physiologically relevant conditions and study the physiological role of various forces and mechanical properties in cells. The findings can help reveal molecular and cellular mechanisms governing biological function and various diseases.